2024 Neural Development Gordon Research Conference and Gordon Research Seminar

Project Summary/Abstract
The 2024 Gordon Research Conference (GRC) on Neural Development at the Renaissance Tuscany II Ciocco
in Lucca, Italy will bring together scientists who investigate fundamental questions related to nervous system
development, using molecular, cellular and organismal approaches. Topics include the genesis of neurons and
glia, cell lineages, cell-cell communication including with non-neural cells, neuronal metabolism, and the
assembly of neural circuitry. The meeting will also probe the basis for brain evolution from molecular to circuit
levels, as well as neurodevelopmental variation and diseases. In line with these diverse topics, speakers employ
a range of classical and emerging model organisms including worms, flies, fish, mice, ferrets, and non-human
primates. They also use state-of-the art complementary models including iPS and ES cells, organoids, and
human tissue. The invited speakers employ diverse approaches including: molecular genetic techniques and
genomic approaches such as transcriptomic and epigenetic profiling; single cell mRNA sequencing and lineage
barcoding; CRISPR-based manipulations and screens; live-imaging and high-resolution microscopy;
neuroimaging and human genetics.
The five-day meeting is designed to promote extensive exchanges between junior and senior scientists from
diverse career stages and backgrounds. This collegial atmosphere will be fostered through interactions at talks,
poster sessions, meals, and informal gatherings during free time. Networking will be promoted with journal
editors and members of funding agencies that support research in this field.
The conference program includes a
diverse range of speakers and discussion leaders from institutions and organizations worldwide, concentrating
on the latest developments in the field.
There will also be many short talks selected from abstracts, which will
especially feature the most exciting recent work by junior researchers
. We encourage applications from diverse
researchers across institutions, career stages, countries, and relevant scientific topics, with the goal of having
diverse participants to enrich the meeting. A GRS is reserved for trainees only, including undergraduate, PhD
students and postdocs; This will precede the meeting, and is organized and run by trainees, and will include
sessions on related topics.

Public health relevance
Project Narrative The 2024 Gordon Research Conference on Neural Development will present work on the formation of nervous systems, from the generation of neurons and glia to their assembly into circuits that drive specific behaviors. State-of-the art approaches will be used across diverse model systems. Discussions will center on neural development, evolution and the basis for neurodevelopmental brain diseases such autism, schizophrenia, and intellectual disability.